Transcriptional Regulation of KCNH2

Summary
Circadian rhythms help to match the optimal function of the cardiovascular system to the daily changes in the
environment. Normal cardiovascular rhythms provide a physiological advantage to people. Unfortunately,
normal circadian signaling can also unmask a time-of-day pattern in adverse events like heart attack, stroke,
and sudden death in patients with underlying cardiovascular disease.
Emerging data now show that abnormal or unhealthy daily rhythms can create a negative impact on normal
health too. For example shiftwork, which repeatedly causes shifts in endogenous circadian rhythms, is an
independent risk factor for cardiovascular disease.
In mammals the suprachiasmatic nucleus (SCN) in the brain is the primary circadian pacemaker that helps to
entrain endogenous rhythms to the environment. SCN rhythms are synchronized to the environment via light,
and its signaling helps to coordinate the molecular rhythms in cells throughout the body. What is new about
this application is we determine how repeated changes in light cycle will impact molecular circadian signaling in
the heart.
Most cells have a molecular clock signaling mechanism that cycles with a periodicity of ~24 hours. We found
genetic disruptions in the molecular clock mechanism of heart cells (cardiomyocytes) primarily causes
abnormal changes in cardiac electrophysiology by disrupting the regulation of ion channel function.
The goal of this application is to determine how repeated shifts in the light cycle impact molecular clock
signaling in the mouse heart and its regulation on ion channel function.
Aim 1. To identify new mechanisms with which the cardiac molecular clock regulates different ion channels.
Aim 2. To determine how repeated changes in light impact molecular clock signaling in the heart and ion
channel regulation.
This project creates new knowledge at the interface between chronobiology and cardiac electrophysiology.

Public health relevance
Project Narrative The molecular clock mechanism serves a ubiquitous cellular time-keeping function, and it regulates the tissue- specific expression of many genes. Molecular clock signaling in cardiomyocytes controls the expression of several K+ channel genes that are important for normal cardiac excitability. We are applying approaches developed in chronobiology to study the regulation of cardiac K+ channels at an entirely new level.